A Novel Cost-Effective Multispecific Therapeutic for Dengue

PROJECT SUMMARY
Dengue remains a major global health concern for which effective prophylactic and therapeutic options are urgently
needed. The heightened dengue burden is driven by several factors including increased urbanization, world
population growth, increased international trade and travel, and changes in human behavior that increase mosquito
breeding sites. After malaria, dengue is the second most frequent mosquito-borne disease that affects humans. To
date, traditional strategies have failed to generate an effective vaccine, and in some instances, vaccination resulted
in enhanced disease. Dengvaxia is the only available dengue vaccine in the US and is only recommended to prevent
dengue in children aged 9-16 years with laboratory-confirmed previous dengue infection. A safety signal in dengue
seronegative vaccine recipients and in children 2-5 years old highlighted increasing evidence of a detrimental effect
of vaccination in certain populations 1. Furthermore, no dengue therapeutic product is approved for intervention
to control a dengue outbreak.
Mapp Biopharmaceutical, Inc. (San Diego, CA), is developing a multi-specific antibody-derived therapeutic product
that synergistically combines the efficacy of two broadly neutralizing antibodies into one half-life extended
molecule. With higher potency (i.e. lower dose), a single dose due to the extended serum half-life, and manufacturing
in microbial host cells, Mapp's objective is to develop a cost-effective dengue immunotherapeutic that will be
globally accessible. Mapp's product candidate is a tri-specific antibody fragment molecule designed to enhance
therapeutic efficacy against dengue virus infection by targeting two distinct epitopes of the envelope protein. This
design aims to broaden coverage and mitigate the risk of escape mutants. Additionally, one arm of the molecule is
designed to bind human serum albumin, extending the therapeutic's half-life. Excluding the Fe region of the antibody
prevents antibody-dependent enhancement of infection, a serious complication linked to the Fe region, and allows
production in microbial host cells, significantly reducing costs.
Mapp has already developed a platform to optimize the design, production, and characterization of the trispecific
molecules. Considering the prevalence and the availability of published potent anti-dengue virus antibodies, Mapp
is strategically investing in developing novel formats that address the specific needs of the dengue disease burden:
potency, safety, and access.
Phase I of this Fast-Track SBIR proposal aims to identify, manufacture, and characterize anti-dengue therapeutics
with a synergistic mode of action. Phase II will involve evaluating the most promising therapeutic candidates in
murine and non-human primate (NHP) models of dengue challenge and initiating IND enabling studies of the lead
candidate.

Public health relevance
PROJECT NARRATIVE Dengue virus poses a risk to half of the global population, causing 390 million infections annually, with record cases and increased mortality in tropical and subtropical regions, and even local transmission in some non-endemic areas. Although two vaccines are available, their effectiveness is limited for certain serotypes, and they may worsen the disease in specific groups. We developed a novel approach to generate a safe, effective, and affordable immunotherapy for dengue that controls outbreaks and protects those for whom vaccination is not recommended or proves ineffective. This approach aims to reduce both the healthcare strain and the economic burden associated with dengue.